MECHANISMS OF INSULIN RESISTANCE SECONDARY TO HYPERGLYCEMIA

To test the hypothesis that hyperglycemia leads to decrease in insulin receptor kinase activity in target tissues, to test the hypothesis that hyperglycemia can induce a kinetic defect and to test the hypothesis that hyperglycemia decreases insulin receptor tyrosine kinase activity through enhanced serine phosphorylation of the insulin receptor.